Collaboration in Regulatory Systems Strengthening and Standardization Activities to Increase Global Access to Safe and Effective Biological Products.

RFA-FD-21-031: PROJECT SUMMARY
Collaboration in regulatory systems strengthening and standardization activities to increase
access to safe and effective biological products.
The overall goal of this continued Cooperative Agreement is to increase access of the global population
to safe and effective biological products for the prevention, diagnosis, and treatment of priority diseases,
especially for use in LMICs. The project aims to achieve oversight of the current status of regulatory
strengthening in priority LMICs; generate the required international framework for global coordination
of regulatory systems strengthening; facilitate and ensure scientific collaboration and enhance
regulatory capacities of National Regulatory Authorities and networks to advance global access to safe
and effective vaccines and other biologicals; support development of science-based and data-driven
norms, standards, guidance and approaches to guide national regulatory authorities; and build a strong
relationship with the US Food and Drug Administration for collaborative efforts in regulatory systems
strengthening and standardization activities in the area of biological products. In line with the Funding
Opportunity Announcement, WHO proposes activities under four objectives: 1: Contributing to
regulatory systems strengthening in low- and middle-income countries; 2: Enhancing post-market
surveillance of vaccines safety; 3: Development of global norms and standards; and 4) Supporting
regulatory mission relevant research and other activities to promote development of and increased
access to safe and effective biological products.
The project will be implemented over 60 months, through 12-months’s phases; managed and
implemented by a Project Management Team and technical staff in WHO Headquarters, regional and
country offices, with ministries of health, national regulatory authorities, national and professional
associations, UN agencies and other relevant partners. WHO draws on a wide network of WHO
Collaborating Centres, NGOs and 50 National Professional Officers in ministries of health worldwide.
Increasing demand for regulatory systems strengthening, increasingly complex global regulatory
environments and more players in the global health arena have prompted WHO to elaborate a new
operational model for regulatory systems strengthening with a Coalition of partner organisations and
the concepts of regional Centres of Excellence, reliance and WHO Listed Authorities. These new
approaches are receiving strong political support from WHO Member States and global health
agencies/partnerships.

Public health relevance
RFA-FD-21-031: PROJECT NARRATIVE Collaboration in regulatory systems strengthening and standardization activities to increase access to safe and effective biological products. Discoveries in medical sciences must be matched with appropriate mechanisms to assure the quality, safety and efficiency of medical products. This is critical for achieving the health-related Sustainable Development Goals and other targets set by the global health community. The international authority on public health, WHO is tasked to lead and coordinate global action to strengthen drug regulatory capacities worldwide and proposes to enter into renewed collaborative efforts with the US Food and Drug Administration to support scientific collaboration and enhance regulatory capabilities of national regulatory authorities in WHO Member States, as well as to strengthen regulatory networks to advance global access to safe and effective vaccines and other biologicals that meet international standards. The overall goal of this continued Cooperative Agreement is to increase access of the global population to safe and effective biological products for the prevention, diagnosis, and treatment of priority diseases, especially for use in LMICs. This will be achieved through scientific and technical collaboration between WHO and FDA/CBER under four research objectives outlines in the Project Summary and in the Research Strategy. WHO plans to implement proposed activities over the course of 5 years, divided into 5 phases of 12 months each. There will continue to be close consultation and collaboration between WHO and FDA/CBER throughout the project. An outline of activities and expected outputs for Phase 1 (months 1‒12); Phase 2 (months 13‒24); Phase 3 (months 25‒36); Phase 4 (months 37‒48) and Phase 6 (months 49‒60). Proposed actions will be implemented with a global, and regional focus, with the active involvement of WHO Regional Offices and relevant WHO Country Offices as relevant. Specific countries have not yet been identified. Collaboration through this Cooperative Agreement continues to be fundamental to the work of WHO in building regulatory capacities and developing relevant global norms and standards to ensure the availability of safe and quality biological products in world markets; and to the implementation of World Health Assembly (WHA) resolution 67.20 on Regulatory systems strengthening for medical products (2014) and resolution WHA 67.21 on Access to bio-therapeutics products – core areas of work for the achievement of health-related Sustainable Development Goals. The increasing number of global health initiatives and institutions that integrate regulatory strengthening into their activities reflects the importance now assigned to quality-assured health products. The FDA’s Centre for Biologics Evaluation and Research /FDA/CBER) is a leader and active participants in the global health community, and thereby an important provider of technical expertise required to shape the global health, including the health research agenda. Interaction with FDA/CBER under this Cooperative Agreement is an essential channel in this regard.